Role of AMP-activated protein kinase in bacterial endophthalmitis - Diversity Supplement

Project Summary/Abstract The proposed supplement activities will not change the parent award project. Please see the Research Strategy.

Public health relevance
Project Narrative The proposed supplement activities will not change the parent award project. Please see the Research Strategy.